Integrated Networks of Scholars in Global Health Research Training (INSIGHT)

PROJECT ABSTRACT
This application presents the Integrated Networks of Scholars in Global Health Research Training (INSIGHT)
Program. We have 145 faculty members across our multidisciplinary and multi-institutional consortium working
together with 24 low- and middle-income countries (LMIC) institutions in sub-Saharan Africa, South Asia, and
the Latin America and the Caribbean. A strategic planning process; including a comprehensive review of our
consortium's role in combatting the global HIV epidemic, emerging and reemerging infectious diseases, non-
communicable diseases, and mental health; was conducted to inform this proposal. A vision statement
encompassing five Themes – Global Impact, Multidisciplinary Science, Integrated Training with Equal
Partnership, Diverse Generation of Global Health Researchers, and Highly Committed Environment–
shapes our work. Key innovations strengthening this proposal include ensuring diversity at the leadership level
and across all research areas; leveraging our institutional commitments in global research training;
amalgamating our strong foundations in clinical, behavioral and laboratory science; enacting a participatory
monitoring and evaluation program; and launching emerging leaders. Aim 1 – Create collaborative,
interdisciplinary global health research that integrates cross-institutional pairing of mentors. The
research training “triad” of US mentor, LMIC mentor, and scholar form a long-term training partnership that
builds research capacity of the scholars and the LMIC partner institutions. Outcomes: Robust interdisciplinary
collaboration engendering innovative research driven by integration and equal partnership between our four
universities and LMIC partners. Aim 2 – Provide one-year research training for 105 scholars with linkage
to the Mentorship Triad Paradigm. We will provide training for five yearly cohorts of 15 scholars (9 US post-
docs, 2 US pre-docs, and 4 LMIC post-docs) in global health research, including coursework and a mentored
research practicum. We will leverage institutional commitment of $1.5 million to support an additional 30
scholars over five years to maximize impact. Outcomes: 90% of scholars completing training will submit grant
proposals and/or publish their research. Aim 3 – Promote and support diversity, equity and inclusion in
global health research training. We will leverage our existing initiatives and affiliations with Minority Serving
Institutions and pipeline programs. This will include broad outreach to departments, centers, and schools at
partner universities; and engaging student groups and associations of underrepresented populations in global
health. Outcomes: 50% of LMIC scholars will be women and at least 30% of US scholars will be from
underrepresented minorities. Aim 4 – Support the transition of scholars into successful and sustainable
research careers. We will link scholar selection to LMIC priorities and research programs. Outcomes:
Sustained collaboration between scholars and INSIGHT consortium researchers for at least five years.

Public health relevance
NARRATIVE The Integrated Networks of Scholars in Global Health Research Training (INSIGHT) consortium formed between the University of Alabama at Birmingham, the Baylor College of Medicine, the University of Maryland Baltimore, and the University of Pittsburgh supports training for the next generation of global health scholars from the US and low- and middle-income countries (LMICs) through mentored research experiences at 24 established partner LMIC institutions across 19 countries in Africa, Asia, and Latin America and the Caribbean. Strong emphases are on a broad range of global health research areas, including combatting the global HIV epidemic and associated co-morbidities, emerging and re-emerging infectious diseases, non-communicable diseases, and mental health.